COMPARISON OF METHODS FOR GFR MEASUREMENTS IN TYPE I DIBETICS

The aim of the proposed study is to determine the accurcy and variabilty of the renal clearance of I-iothalamate after subcutaneous bolus administration in type 1 diabetics who fulfill the eligibility criteria for entry into the DCCT. We propose to compare, in 20 subjects, in two measurements performed one month apart, simultaneous renal clearances of inulin during a continuous intravenous infusion (the "gold standard"), meglumine (non-radioactive) iothalamate during a contiuous intravenous infusion, and I-iothalamate after a subcutaneous bolus. Inulin will be assayed by the anthrone method, non-radioactive iothalamate will be assayed by high performance liquid chromatography (HPLC), and I- iothalamate will be assayed by emission counting. GCRC support is requsted only for Core Lab support to measure serum and urine inulin concentrations.